Nutrigenetics and Nutrigenomics for Precision Weight-Loss Diet Interventions

Abstract
Excessive postprandial glycemia has emerged as a key factor regulating energy intakes and driving obesity
and cardiometabolic diseases, and recent studies highlight the rising importance and urgent need of mapping
the individual variability of postprandial glycemic response in precision nutrition and diet interventions. The
proposed systems study aims to fill this significant research gap. Our study will build upon the unparalleled and
complementary resources from three diet intervention trials and cohort: The OmniCarb trial, The POUNDS
LOST trial, and The Precision Health Study (PHS). We will analyze associations of the usual levels of fasting
plasma metabolome and postprandial metabolomic changes with postprandial glycemic response in the meal
challenge tests (Aim 1); and analyze the dynamic changes (5 weeks, 6 and 24 months) in postprandial
glycemic variability-related metabolites in response to diet interventions varying in glycemic index (GI) and/or
carbohydrate intakes (Aim 2). We will also examine the relations of changes in postprandial glycemic
variability-related metabolites with changes in appetite, energy intake and expenditure (Aim 3). In addition, we
will examine the temporal sequence and mediation effects of postprandial glycemic variability-related
metabolites in the relation between diet interventions and cardiometabolic changes (Aim 4). The proposed
project aligns well with the special interest of NIH in ‘Nutrigenetics and Nutrigenomics Approaches for Nutrition
Research (NOT-DK-19-019)’ and precision nutrition. Our study will provide novel insights into the intrinsic
determinants of individual variability in postprandial glycemic response, and contribute significantly to the
development of novel precision diet interventions. The findings from our study will have wide public health
applicability and clinical implications.

Public health relevance
Narrative In three complementary diet intervention trials and free-living cohort, our systems study investigates the dynamic relations of circulating metabolome and postprandial metabolomic changes with postprandial glycemic variability, energy intake and expenditure, as well as cardiometabolic changes in response to diets varying in glycemic index (GI) and/or carbohydrates. Our study will contribute significantly to identification of the intrinsic determinants of individual variability in postprandial glycemic response, and the development of novel precision diet interventions.